OPTION 1 FOR BUSINESS PROCESS REENGINEERING (BPR) SERVICES

The Business Process Reengineering (BPR) Project's purpose is to facilitate administrative/operational process improvement efforts. This contract supports BPR engagements.